Towards a reliable and valid assessment of preteen suicidal thoughts and behavior

Project Summary
The preteen years are a critical period in which to study the development of suicidal thoughts
and behavior (STB). During this period, youth experience changes in emotion regulation and
develop cognitive capacities that include an emerging understanding of the permanence of
death, which in turn affect the expression of STB. However, as noted in the 2021 NIMH-
Sponsored Research Round Table Series: Risk, Resilience, and Trajectories in Preteen
Suicide, research on preteen STB has been hindered by the field’s failure to focus on an
accurate, and thorough, assessment of STB in this age group.This application seeks to
develop and test a comprehensive approach to the assessment of preteen STB that includes
child and parent/guardian self-report, clinician interviews, an implicit association test, a death
understanding interview, and observational measures. In order to address this question, this
application will examine both concurrent and predictive validity of the assessment approach in
preteens receiving intensive psychiatric services (inpatient or partial hospitalization) who have
a range of internalizing and externalizing symptoms, as well as a range of STB. We will recruit
360 preteens at Bradley Hospital/Brown Medical School and the Johns Hopkins School of
Medicine, ensuring a diverse sample of children. In addition to refining the assessment of
preteen STB, we will also: 1) conduct a thorough clinical assessment of related
symptomatology to better inform clinical practice, and 2) examine mechanisms hypothesized
to underlie preteen STB, using an RDoC-informed approach. We will also examine which co-
occurring symptoms and mechanisms significantly improve predictive validity for adverse
clinical STB outcomes above that of the STB assessment alone. This assessment approach is
innovative in that it is the first study to develop a multi-modal, multi-informant assessment
approach for preteen STB including use of real-time observational strategies, as well as an
implicit association test. This is significant because we are studying the most high-risk
population of preteens with STB and we will be able to delineate mechanisms related to
preteen STB. This work addresses: NIMH Strategic Objective 2.1.B “Characterize the
emergence and progression of mental illnesses”, 2.2.A “Determining early risk and protective
factors and related mechanisms”, and 2.2.B“Developing reliable and robust biomarkers and
assessment tools to predict illness onset, and course, across diverse populations”.

Public health relevance
Project Narrative This project is designed to study suicidal thoughts and behavior in a sample of young children, 8 to 11 years old, who are being treated for emotional and behavioral difficulties. The goal of the study is to better understand suicidal thoughts and behavior in preteen children. Specifically, if these thoughts and behaviors lead to future suicidal thoughts and behavior and psychiatric care over a 12-month follow-up period.